Core 3: Biocontainment Research Support Services Core

ABSTRACT- Biocontainment Research Support Services Core (Core 3)
The central mission of the Duke RBL is to support the basic and translational research necessary to develop
drugs, diagnostics, and vaccines for emerging/reemerging infections and biodefense. Support through this
award will allow us to expand our existing services to refine our small animal models programs, thus providing
a wider range of services offered to the research community. It will also render our virology program more
effective, particularly through the development of a direct workflow from our clinical laboratories at Duke, in
addition to relying on third party sources, particularly for rapidly emerging viral variants. Thirdly, we will
broaden our range of immunological assays performed in our BSL-3 suites, such as live cell flow sorting and
rapid evaluation of cytokine and biomarker profiles. The goals of this Biocontainment Research Support
Services Core (Core 3) are to 1) establish, maintain, and provide small animal challenge models with BSL-3
pathogens through the Duke RBL Animal Models Research Support Services; 2) maintain and provide quality-
controlled virus inventory of Select Agents and pathogens requiring BSL-3 conditions through the Duke RBL
Virology Research Support Services; and 3) provide comprehensive immune monitoring at BSL-3 via humoral,
cellular, and biomarker analysis through the Duke RBL Immunology and Flow Cytometry Research Support
Services. Implementation of these three Aims will allow us to expand the capabilities and services that we can
offer not only to the Duke community, but also to our neighboring institutions and the national RBL network.